Quantification of Liver Fibrosis with MRI and Deep Learning

Project Summary/Abstract
Chronic liver disease (CLD) is a common cause of morbidity and mortality in the U.S. and throughout the
world. In 2017, CLD had an age-adjusted death rate of 10.9/100,000 total population and an estimated lifetime
cost of fatty liver disease alone in the U.S. of ~$222 billion. Liver fibrosis (LF) is the most important and only
histologic feature known to predict outcomes from CLD. The current standard for assessing LF is biopsy, which
is costly, prone to sampling error, and invasive with poor patient acceptance. Thus, there is an urgent unmet
need for noninvasive, highly accurate and precise diagnostic technologies for detection and quantification of LF.
Our overarching objective is to apply Deep Learning (DL) methods using conventional non-elastographic
magnetic resonance (MR) images, MR elastography (MRE), and clinical data to accurately detect and measure
LF in children and adults with CLD, using biopsy-derived histologic data as the reference standard. In this project,
we will dedicate our efforts to accomplishing the following specific aims. In Aim 1, we will develop and validate a
DL framework to accurately segment liver and spleen in order to extract radiomic (gray-scale signal intensity
distribution, shape and morphology, volumetry, and inter-voxel signal intensity pattern and texture) and deep
features (complex abstractions of patterns non-linearly constructed throughout the transformation estimated by
data-driven DL training procedures) from conventional multiparametric MRI. These features allow detection of
liver and spleen structural abnormalities/tissue aberrations. In Aim 2, we will develop and validate an “ensemble”
DL model (LFNet) to predict biopsy-derived LF stage and LF percentage using the integration of conventional
multimodal MRI radiomic and deep features, MRE data, as well as clinical data. In Aim 3, we will develop and
validate a DL model (LSNet) to quantify MRE-derived liver stiffness (LS) using conventional multiparametric MRI
radiomic and deep features as well as clinical data. The proposed models will help physicians to more accurately
detect and follow CLD by 1) quantifying LS from conventional MR imaging without the need for MRE; and, more
importantly, 2) predicting histologic LF stage and LF percentage without the need for biopsy, while avoiding inter-
radiologist variability, reducing radiologist workload, and ultimately reducing healthcare costs. We will validate
the models using both internal and independent external data from various scanners and sites. The techniques
we develop are expected to improve medical diagnosis and prognostication in the same way as DL has
revolutionized other fields. This study will significantly impact public health because it will allow physicians and
researchers to more accurately diagnose and quantify CLD and LF as well as permit more frequent assessments
in a noninvasive, patient-centric manner, thus potentially improving patient outcomes while lowering healthcare
costs. The techniques we develop also can be readily extended for the prediction of other important liver-related
clinical outcomes, including impending complications such as portal hypertension, time to liver
transplant/transplant listing, and mortality risk, among others.

Public health relevance
Project Narrative Chronic liver disease (CLD) is a common cause of illness and death worldwide, and it is a significant healthcare and financial burden. Liver fibrosis (LF) is a measurable feature of CLD that is important to assess the severity of disease, evaluate for progression and therapy response, and predict outcomes. We propose to apply artificial intelligence methods to noninvasive conventional magnetic resonance images and readily- available clinical data for accurate detection and quantification of LF, thus significantly impacting public health by facilitating personalized therapies without the need for liver biopsy, improved outcomes, and lower healthcare costs.